Alliance Statistics and Data Management Center

Project Summary
The Alliance for Clinical Trials in Oncology (Alliance) was founded on July 15, 2011, through the merger of 3
legacy groups: Cancer and Leukemia Group B, North Central Cancer Treatment Group, and American College
of Surgeons Oncology Group. The Alliance Statistics and Data Management Center (SDMC) is responsible for
all statistics, data management, and Information Technology functions for the Alliance and, as such, is an
integral part of the Alliance’s mission. Despite being formed from 3 distinctive groups, all SDMC activities are
now consolidated at a single location at the Mayo Clinic under the leadership of Dr. Sumithra Mandrekar as the
Alliance Group Statistician, all while undergoing a leadership transition due to the untimely death of the
previous group statistician, Dr. Daniel Sargent. Alliance faculty includes methodological leaders in biomarker-
based clinical trial design, adaptive trials, surrogate endpoint evaluations, development of methodology and
computing tools for identification of predictive genomic markers, and early-stage clinical trial design. From
March 1, 2014 – August 31, 2017, the SDMC provided statistical, data management, and IT collaboration for 20
treatment trials currently in development, 21 treatment trials that opened to accrual and, 100 trials that opened
prior to March 2014, for which patient follow-up or manuscript preparation is in progress. SDMC members
were authors on 234 published manuscripts reporting on Alliance- led clinical trials and associated correlative
or retrospective studies, authored an additional 149 reviews, editorials, or position papers on novel statistical
and bioinformatics methods, analyses and software, and provided substantial statistical support and leadership
on 44 publications which leverage individual patient data from multiple Alliance studies. SDMC systems are
robust and scalable and support all needs of the Alliance. The SDMC has implemented Medidata Rave for all
trials, consolidated to a single information systems infrastructure, met all NCI OEWG timelines, collaborated
on international trials, partnered on prospective and retrospective registration trials, and is leading the
ALCHEMIST trial, A151216 (part of the NCI precision medicine initiative). The SDMC has contributed to
several national NCTN systems initiatives: piloting of the ePRO system, Source Data Verification, integrations
between Rave and CTEP- AERs, implementing the Data Quality Portal and Central Monitoring Portal, and
partnering on the NCTN Biospecimen Navigator. The Alliance SDMC has kept pace with, and in many cases
led, innovation in scientific, administrative, and technological arenas of cancer research, and is ideally poised
to meet the challenges of cancer clinical trials in 2018 and beyond.

Public health relevance
Project Narrative The Alliance Statistics and Data Management Center is responsible for the statistical, bioinformatics data management, and information technology activities that support the scientific agenda of the Alliance for Clinical Trials in Oncology, a national cancer research organization.